Mouse Model Core

The UTHSC-Mouse Model Core Laboratory (Core C) will be directed by Dr. Eva M. Zsigmond. Dr. Zsigmond has extensive experience in the generation, identification and breeding of both transgenic and gene-targeted mouse models. The specific aims of the Core C are the following: 1. Generate knock-in mice carrying Acta2 or Myhll mutations. 2. Breed and maintain appropriate lines of these genetically-manipulated mice for various projects within the program. Core C will provide overall colony maintenance and the testing needed for the backcrossing of the colony. 3. Collect, store and make mouse tissues and primary cells available to the other projects. Core C will explant smooth muscle cells from the mouse aortas and provide these primary cultures from the genetically altered mouse models to the PPG investigators.

Public health relevance
RELEVANCE (See instructions): Centralizing the generation of animal models for this PPG in one core facility will result in significant savings of time and money. The availability of mouse models of the ACTA2 or MYH11 gene dysfunctions will provide the PPG investigators with unique animal models for their studies of the physiological and pathophysiological roles of the vascular smooth muscle cells in aortic aneurysms, strokes and other cardiovascular artery diseases.